Development and Support of the Pathway Tools Software

Project Summary
The huge breadth and depth of data and knowledge deﬁned by the genome sequence of an organism, and by
large numbers of other experimental ﬁndings for the organism, requires a database (DB) as a central repository
for information about the genome, the biochemical network, and the regulatory processes of that organism. The
Pathway Tools software is a robust and comprehensive system for constructing such organism-speciﬁc DBs. Path-
way Tools enables communities of scientists to create, query, visualize, and analyze organism DBs, and to publish
such DBs on the web. The software supports construction of organism DBs that combine a large number of bioin-
formatics datatypes, including genome maps, genes, operons, RNAs, proteins, chemical compounds, biochemical
reactions, metabolic pathways, and regulatory interactions. Pathway Tools further enables inference of qualitative
metabolic reconstructions from sequenced genomes, and the creation of quantitative metabolic ﬂux models from
those reconstructions. Such metabolic models enable computational predictions of which genes and reactions
within the metabolic network are essential, thus facilitating the design of drugs against disease-causing bacteria.
We propose to research several new inference algorithms that derive new information for a sequenced
pathogen genome for inclusion in Pathway Tools DBs. One algorithm will detect cross-feeding and cofactor-
exchange relationships within a community of organisms to advance mechanistic understanding of the human
microbiome. A second algorithm will enable rapid communication of the biochemical machinery of an organism
encoded in its genome to scientists, such as during a disease outbreak. A third algorithm will improve the pre-
diction of operons within bacterial genomes based on new features including RNA-seq data. We also propose to
implement a suite of cloud-based editing tools for Pathway Tools databases that execute within the user's web
browser. These editing tools will enable communities of scientists to work together to update and share knowl-
edge about a given genome.
Pathway Tools is a mature and production-grade software environment that 10,800 research groups around the
world have licensed, and it has been cited 1,650 times. We propose to maintain the software, such as by installing
new versions of its many components, and to support its user community through training, documentation, and
bug ﬁxing.

Public health relevance
Project Narrative The proposed project will generate software tools that increase the ability of scientists to use genome sequence data to advance human health. This software enables creating central database repositories and websites contain- ing genome data and data on cellular networks for disease-causing bacteria such as Mycobacterium tuberculosis. The software will enable researchers to computationally detect cross-feeding relationships between bacteria within the human microbiome to develop a mechanistic understanding of the microbiome to advance health.